Unraveling the systemic manifestations of pulmonary arterial hypertension on lean muscle mass

Project Summary
While pulmonary arterial hypertension (PAH) is a progressive disease of the pulmonary vasculature
associated with high morbidity and mortality, it also has multiple systemic manifestations affecting many
organs. There is a growing body of evidence suggesting respiratory and skeletal muscle dysfunction in patients
with PAH; however, loss of muscle mass has not been adequately studied in PAH. Loss of lean mass is
increasingly recognized in individuals with chronic conditions and when present, is associated with decreased
physical activity and worse outcomes. Our preliminary data shows that almost 42% of patients with PAH
enrolled in a prospective observational cohort had low lean mass and obese individuals had a higher
prevalence of low lean mass as compared to individuals with normal weight. Fat depots are metabolically
active and produce an array of inflammatory cytokines and adipokines that likely contribute to the muscle loss.
We are proposing a comprehensive evaluation of lean mass in patients with PAH. First, in a prospective
cohort of patients with PAH, we will characterize the endophenotype of PAH patients with low lean mass and
identify the metabolomic signature of low lean mass which will provide us with insight into novel putative
pathways. We also aim to understand the role of epicardial adipose tissue in the pathogenesis of low lean
mass. We will assess the impact of low lean mass on patient-centered outcomes including quality of life,
physical activity, and hospitalizations. Second, we will identify radiographic features of muscles on thoracic
non-contrast chest CTs to allow for earlier and easier screening for low lean mass in patients with PAH. Finally,
we will conduct a small pilot study to explore the response of adiponectin and muscle oxygenation to a low-
resistance exercise intervention in patients with PAH. The results of this study will lay the foundation for
“personalized” interventions trial targeting low lean mass in PAH.

Public health relevance
Project Narrative Patients with pulmonary arterial hypertension (PAH) are at increased risk of muscle loss and decreased physical activity. This proposal will aim to (1) understand the underlying pathologic mechanisms that contribute to muscle loss in PAH, particularly focusing on the role of the fat surrounding the heart, and (2) assess the impact muscle loss has on quality of life, daily physical activity, and hospitalizations in patients with PAH. Finally, in a small pilot study, we will also explore how a low resistance exercise intervention may improve muscle mass for PAH patients.